Assessing the impact of a postpartum intrauterine device intervention on contraceptive decision-making

PROJECT SUMMARY/ABSTRACT
Significance: Long-acting reversible contraceptives (LARCs) are recommended first-line as they are safe and
highly effective. Yet LARCs are not widely adopted in low- and middle-income countries (LMICs). Over the last
decade, family planning programs have increasingly promoted LARCs in LMICs. While ensuring LARC access
is imperative, overzealous promotion of LARC initiation or limited access to LARC removal services may inhibit
reproductive autonomy. Women without reproductive autonomy face adverse health outcomes, have increased
medical mistrust, and are less likely to utilize contraception. Yet, no quantitative studies have examined the
impact of LARC promotional programs on reproductive autonomy in LARC initiation and discontinuation.
Specific Aims: The proposed project will (1) assess whether a postpartum intrauterine device (IUD)
intervention was associated with perceived pressure to adopt contraception that influenced contraceptive
decision-making, (2) examine longitudinal patterns of IUD removal and access to removal by marital status,
parity, and pressure to adopt contraception, and (3) qualitatively understand women’s experiences with
autonomy when seeking IUD removal.
Approach: The proposed analyses will utilize data collected by the Postpartum Intrauterine Device (PPIUD)
Study, a step-wedged cluster randomized trial of a postpartum IUD intervention that was conducted in
Tanzania and Nepal. The intervention involved provider training in contraceptive counseling and PPIUD
insertions. Aim 1 will utilize multinomial logistic regression to estimate the association between the intervention
and a novel, person-centered measure of reproductive autonomy, whether perceived pressure to adopt
contraception influenced contraceptive decision-making. Aim 2 will apply robust survival analysis techniques to
examine whether sociodemographic factors are associated with access to IUD removal over time. Aim 3 will
use an explanatory mixed-methods approach to contextualize findings by qualitatively exploring women’s
experiences with autonomy when seeking IUD removal services.
Fellowship Information: The applicant is a PhD student in epidemiology at the University of North Carolina at
Chapel Hill (UNC), a predoctoral trainee in an NICHD-funded T32 training program in reproductive
epidemiology, and a predoctoral trainee in population sciences at the Carolina Population Center. Through
interdisciplinary training and mentorship that spans public health, social science, medicine, and bioethics and
integrates causal inference and mixed-methods approaches and UNC’s rigorous and collaborative research
environment, the proposed training plan will provide the applicant with the resources she needs to successfully
complete her doctoral dissertation and pursue her long-term goal of becoming an independent investigator
focused on reproductive epidemiology and family planning.

Public health relevance
PROJECT NARRATIVE Long-acting reversible contraceptives (LARCs) are often promoted in low- and middle-income countries, yet qualitative studies suggest that LARC promotion can inhibit reproductive autonomy through overzealous encouragement for uptake and barriers to removal, thereby impacting public health and human rights. This mixed-methods study will use secondary data collected as part of the Postpartum Intrauterine Device (IUD) Study in Tanzania and Nepal to examine if and how a postpartum IUD intervention impacted women’s experiences with autonomy in contraceptive decision-making and IUD discontinuation. The proposed aims align with NICHD’s strategic goal of “setting the foundation for healthy pregnancies and lifelong wellness” and can be used to inform future family planning programs that aim to increase contraceptive access and support reproductive autonomy.